Characterizing patients at risk for sepsis through Big Data (Supplement)

“Ethics and Equity in Developing Artificial Intelligence models for Patients at Risk of Sepsis”
SUMMARY
The goal of this K23 supplement application proposal is to create ethical, disease-specific statistical bias
detection for prediction models. The proposal introduces the first two steps of such as system: convene a
ethics-driven focus group to identify important demographic factors for which to consider correcting, when
applicable; and (2) create a novel bias detection metric, “Selection and Information Bias Exposure and Rank”
or SIBER, which details the involvement and relative importance of each demographic factor (selected by the
focus group) to the prediction output of existing models. In the first part of the workflow, a multidisciplinary
group of ethicists, data scientists, clinicians, and community-based healthcare advocates are asked to attend
three 2-hour sessions focused on improving health equity in the disease of interest (e.g., sepsis). At the end of
the three sessions, the group is expected to have identified the demographic groupings needed for the
algorithmic component. The data from the focus groups will be analyzed using qualitative analytic techniques.
Among the results will be the list of demographic groups/labels that are at risk for experiencing healthcare bias.
A utility function of each demographic variable will be created to weigh their relative importance in prediction
output, but only among those who are deemed at high risk of bias. (The process for determining bias is beyond
the scope of this proposal, but will be in future work.) The bias detection system (SIBER) will be exposed to
two different sepsis prediction models, one of which being the model deliverable for aim 1 of my K23. The
models will determine sepsis risk on unseen data. The proposal will test the ability of SIBER to identify and
rank the different demographic factors contributing to wide prediction intervals.
This supplement builds upon the ongoing work of aim 1 in the parent K23 award, which is to derive
and validate SOS using electronic medical record data. Sepsis is the test case to prove the utility of
SIBER, but the work proposed in this supplement is critical to creating equitable predictive models in general. It
demonstrates that selection and information bias is present in the electronic medical record, and attempts to
link it with certain demographic factors. It is the first step in operationalizing healthcare justice using data. It
also demonstrates the intersectionality that exists between many demographic factors.

Public health relevance
PROJECT NARRATIVE Artificial Intelligence (AI)-based software could be very powerful tools to predict diseases before they happen, but they are only as good as the data given to them. AI tools designed to predict a disease very well in one group may do poorly at predicting in another if it hasn’t been exposed to that data, or the data collected differently. Our society recognizes that certain groups like Black Americans and certain immigrant communities have been historically disadvantaged; social biases may mean that they are not represented or misrepresented in the data used to train these software. Our goal is to create new “helper” tools that can identify reasons that AI tools predicting certain diseases make the decisions that they do. They’ll identify what aspect of a person’s identity might have contributed most. We hope this work will improve AI tools so everyone can benefit equally from them.